FoxO1 in Beta-Cell Compensation

Abstract: This is a renewal application. During the previous funding period, we have made significant progress toward our understanding of pancreatic β-cell compensation — an adaptive mechanism by which β-cells increase insulin secretion to overcome insulin resistance for maintaining euglycemia in obesity. β-cell compensation also ensues during pregnancy to override maternal insulin resistance for accommodating the rising metabolic demand of insulin from the fetus and mother. Failure of β-cells to compensate for obesity- or pregnancy-elicited insulin resistance results in insulin insufficiency, contributing to the onset of type 2 diabetes or gestational diabetes. It remains elusive how β-cells compensate for insulin resistance and what causes β-cell failure. Our studies characterize FoxO1 as a pivotal factor for β-cell compensation. FoxO1 loss-of-function impairs β-cell compensation, resulting in fat-induced diabetes, whereas FoxO1 gain-of-function augments β-cell compensation, preventing glucose disorder in dietary obese male mice. Female mice with β-cell FoxO1 depletion maintain euglycemia, but during pregnancy, all female β-cell FoxO1-knockout mice develop fasting hyperglycemia and glucose intolerance and abnormal glucose-stimulated insulin secretion, characteristic of gestational diabetes. To deepen our understanding of the mechanism by which FoxO1 regulates the adaptive changes of β-cell mass and function in response to overnutrition or pregnancy, we proposed two aims: 1) To determine the mechanisms by which FoxO1 integrates nutrient and insulin signals to β-cell compensation for insulin resistance in diet-induced obesity, and 2) To characterize FoxO1 in gestational β-cell compensation for maternal insulin resistance and determine the contribution of FoxO1 deregulation to gestational diabetes. Accomplishing this project will provide potential therapeutic avenues for augmenting β-cell compensation to prevent the onset of diabetes in at-risk subjects with morbid obesity or gestational diabetes.

Public health relevance
Narrative: Type 2 diabetes results from β-cell failure, culminating in the disability of β-cells to compensate for insulin resistance in at-risk subjects with obesity. The fact that diabetes develops in some but not all insulin resistant subjects with obesity forebodes an intricate interplay between genetic and nutritional cues in β-cell failure. Our goal is to characterize the genetic factor(s) that integrate β-cell compensation with nutrient signals to understand the mechanism of β-cell failure in diabetes.